Biostatistics and Database Core

The Biostatistics and Database Core E is an integral part of this program project grant (PPG) “From cells to
complex syndromes: Using networks to understand heterogeneity in TDP-related frontotemporal degeneration
and aging” at the University of Pennsylvania (Penn) Perelman School of Medicine (PSOM). The goal of Core E
is to support the data management, database, statistics, bioinformatics, and related computational needs of the
PPG investigators. The services provided by Core E include: (a) support for data form/questionnaire design
and development, database development and management, data entry, database audit trail, database security,
database backup, and stringent data quality control procedures, (b) computing and programming support for all
PPG activities, including implementation and integration of hardware and software upgrades necessary for
data management and research, routine and archival off-site backup of computing systems central to the PPG,
(c) biostatistical support for all study aspects of Projects and Cores from inception to publication, including
development of study design, performing sample size and power calculations, and performing analyses of the
PPG data, (d) support graph theoretic analysis in collaboration with the Neuroimaging Core C, (e)
development of new statistical methodologies and extension of existing methodologies where needed for
analyses of the PPG data, Thus, Core E plays an important and significant role that is critical to the progress of
research and the conduct of studies in the PPG.